Project SMART: Social Media Anti-vaping Messages to Reduce ENDS Use Among Sexual and Gender Minority Teens

PROJECT SUMMARY. Sexual and gender minority (SGM) youth, inclusive of lesbian, gay, bisexual,
transgender, and queer individuals, are more likely to initiate ENDS use (or vaping) and to currently vape than
non-SGM youth. The parent R01 of this proposed supplement Project SMART (Social Media Anti-Vaping
Messages to Reduce ENDS Use Among Sexual and Gender Minority Teens; R01DA054236-01) is to evaluate
the effectiveness of an SGM-tailored social media intervention to prevent vaping initiation among SGM youth
ages 13-18 years. Scientific Rationale: The reach of evidence-based SGM-targeted tobacco prevention
interventions is often inadequate due to barriers that limit the outreach, implementation, and maintenance of
these programs. There is a critical gap in stakeholder engagement to narrow the research-practice gap such
vaping prevention interventions developed for SGM youth are appropriate for real-world practice settings and
meet the needs of future adopters. Objectives: The primary objective of this supplement in response to NOT-
OD-22-032 is develop a multifaceted implementation strategy that can be utilized by potential implementers of
the anti-vaping campaign intervention among SGM youth we are developing in Project SMART. The long term
goal is to increase the reach, adoption, implementation and maintenance of the anti-vaping social media
intervention to prevent vaping among SGM youth. Specific Aims: 1) Describe the implementation barriers,
facilitators, and needs among future adopters and implementers of an anti-vaping social media campaign for
SGM youth, 2) Identify the determinants that would make the campaign more likely to be adopted,
implemented and maintained, 3) Use the data collected to inform a set of implementation strategies that are
both feasible and acceptable to best meet the specific needs and contexts of each future adopters and
implementer. Research Strategy: For this study, we will tailor Fernandez and colleagues' (2019)
Implementation Mapping approach and: 1) conduct an implementation needs assessment among program
implementers of the anti-vaping social media intervention, 2) determine the program implementation outcomes,
performance objectives, determinants, and matrices of change objectives with program implementers (e.g.,
identifying what are facilitators and barriers to conduct the anti-vaping social media campaign), and 3) select
theoretical methods and design implementation strategies. Participants will be 10-12 potential program
implementers who will have a high level view of the context in which the anti-vaping social media campaign for
SGM youth could be integrated within their health promotion efforts across diverse organization type, sector,
and geographic region (e.g., national, state and local health agencies, professional groups, SGM youth
community centers). Impact: This completion of this supplement research will lead to a theory and practice-
informed implementation protocol to enhance the reach, adoption, implementation and maintenance of Project
SMART's anti-vaping social media intervention among future implementers.

Public health relevance
PROJECT NARRATIVE This supplement request will enhance the activities of the parent award (Project SMART; R01DA054236) because we will obtain inputs from stakeholders who are future implementers of the anti-vaping messaging intervention at the design and testing phases to increase the potential reach, adoption, and public health impact of the intervention. This study is expected to yield novel data to inform the design of a multifaceted implementation protocol to promote anti-vaping messages among SGM youth on social media across a variety of contexts. By engaging stakeholders who conduct health promotion efforts at a variety of community settings and geographic locations, we are ensuring that the anti-vaping social media intervention is culturally appropriate and that the proposed approach will consider contextual and organization facilitators and barriers.